Mitoapocynin, a novel NOX2 inhibitor, mitigates nerve agents induced longterm neurotoxicity

Abstract
Chemical warfare nerve agents (CWNA) are increasingly used to attack civilians worldwide. Currently, we lack
effective treatment for CWNA survivors. Until recently, preventing acute death due to CWNA exposure had
taken a top priority. However, reports on the life-long health consequences of sarin attack survivors are
beginning to emerge. Like organophosphates (OPs), CWNAs are cholinesterase inhibitors and potent
seizurogenic agents. In animal models, acute CWNA/OP exposure induces status epilepticus (SE) and other
cholinergic symptoms. The current medical countermeasures (MCM) such as atropine, oxime, and
diazepam/midazolam control symptoms, but do not prevent long-term neurotoxicity and comorbidity, primarily
due to persistent nitrooxidative stress, neuroinflammation, and neurodegeneration. We predict that a
combination of neuroprotectant and MCM can prevent CWNA-induced long-term neurotoxicity. We propose
to investigate the long-term neuroprotective and antiepileptogenic effects of a novel inhibitor of NADPH
oxidase (NOX2), mitoapocynin, in rat diisopropylfluorophosphate (DFP) and a nerve agent soman models.
As proof of concept, we demonstrated the neuroprotective and disease-modifying properties of NOX2 inhibitors
in the rat DFP and the mouse Parkinson's disease (PD) and seizure models. Treating mice or rats with
mitoapocynin before the induction of SE with kainate (KA) or DFP significantly prevented the onset of convulsive
seizures suggesting its anti-seizure property. We further tested mitoapocynin and diapocynin in telemetry-implanted
rats after inducing SE with KA or DFP and treating them with MCM. Both NOX2 inhibitors are blood-brain barrier
permeable. They prevented epileptogenesis in >50% rats and significantly reduced reactive gliosis and
neurodegeneration. Although we had tested the proof of concept for the role of NOX2 in the rat DFP model,
the optimum dose of diapocynin used was too high (300 mg/kg), which cannot be extrapolated for human
use. Therefore, we developed, characterized, tested in vivo, and patented (US8962600 B2) the
mitoapocynin, which is effective at 10-30 times lesser dose than diapocynin. Our overarching hypothesis
is that mitoapocynin counteracts CWNA-induced long-term neurodegeneration, epileptogenesis, and restores
brain function. We will investigate this in both male and female rat DFP models (Specific Aim 1) and validate
in soman model (Specific Aim 2). We will expose rats to DFP/soman, treat with MCM, and 2h later with
mitoapocynin (30 mg/kg, oral) or vehicle twice daily for the first three days, and 6 weeks later conduct a battery
of behavioral tests. We will implant a telemetry device to monitor SRS and disease progression/modification
in real-time. To determine the protective effect of mitoapocynin, we will conduct brain histochemistry for
neurodegeneration and neuroinflammation, nitro-oxidative stress assays, and multiplex assay for cytokines.
Our proposal embodies a novel translational approach targeting both neurodegeneration and epileptogenesis
and may yield a novel orally-active therapy for CWNA-induced long-term neurotoxicity.

Public health relevance
Project Narrative Organophosphate nerve agents such as sarin and soman are classified as extremely lethal chemical warfare nerve agents (CWNA) likely to be abused in terrorism. The civilian populations are at risk if they are exposed to CWNA, which will cause deaths at high concentrations but sublethal concentrations will cause acute seizures and brain disorders for lifelong if they are not adequately treated immediately. The current medical countermeasures (MCM) alone are inadequate to prevent the long-term neurological problems, therefore we propose to test a combination of MCM and a neuroprotectant, mitoapocynin (a highly selective NADPH oxidase inhibitor) in rat DFP and soman models.